Chemical Countermeasures Research Program (CCRP) Product Development Support Services for Medical Countermeasures (MCMs) Against Chemical Threats

The primary objective of this project is to support the research and early development of MCMs against chemical threats (e.g., chemical nerve agents, vesicants, toxic industrial chemicals and materials (TICs and TIMs), choking and cellular respiration agents, and toxins).